Augmenting Pulsatile Growth Hormone: Metabolic Effects in HIV-Infection

DESCRIPTION (provided by applicant): More than half of individuals treated for HIV-infection now demonstrate changes in body fat distribution, including increased visceral adiposity and peripheral fat atrophy. Along with these changes, HIV-infected patients are at increased risk for insulin resistance, diabetes, dyslipidemia, and cardiovascular disease. This grant proposal investigates a novel strategy to decrease abdominal fat and reduce metabolic risk in HIV- infection by augmenting endogenous growth hormone (GH) secretion through the use of growth hormone releasing hormone (GHRH1-44). The rationale for this strategy stems from data that HIV-infected patients with abdominal fat accumulation are relatively GH deficient, and from clinical observations that GH replacement in other populations with GH deficiency improves body composition and ameliorates cardiometabolic risk. The use of GHRH1-44 in this application, in contrast to the use of exogenous recombinant human GH (rhGH), is proposed in order to augment physiologic pituitary GH secretion rather than providing apulsatile exogenous replacement. Our preliminary data demonstrate that GHRH1-44 increases endogenous pulsatile growth hormone secretion, which we hypothesize will lead to greater efficacy and reduced side effects as compared to exogenous rhGH. Previous studies have demonstrated that GHRH1-44 reduces visceral fat accumulation and improves dyslipidemia. In this proposal we hypothesize that GHRH1-44 will also decrease ectopic fat in liver and muscle, potentially ameliorating insulin resistance. Two studies are proposed in this application - a short-term comparison of the effects of GHRH1-44 vs. rhGH on endogenous GH pulsatility and insulin sensitivity, and a 1 year randomized placebo-controlled trial measuring the effects of GHRH1-44 on lipolysis, insulin sensitivity, and ectopic fat accumulation. Together, data from these studies will characterize the metabolic effects GHRH1- 44 and, additionally, will explore the physiologic importance of GH pulsatility by contrasting the effects of GHRH1-44 vs. rhGH. With these goals, the proposed research will both enhance our understanding of GH physiology and contribute to the development of a potentially important new treatment strategy for metabolic complications of HIV. The candidate in this application, Dr. Takara Stanley, is a pediatric endocrinologist with clinical research experience in metabolic and endocrine complications of HIV-infection. Dr. Stanley's career goal is to perform patient-oriented research in an academic setting, focusing on the metabolic and endocrine aspects of body fat distribution. In the current proposal, Dr. Stanley will explore these themes through the model of HIV-lipodystrophy. As she progresses in her career, she plans to expand her field of investigation to pediatric conditions of abdominal obesity. The proposed studies will provide Dr. Stanley with experience and training in numerous methods of physiologic investigation, including techniques for analyzing hormone secretory dynamics, glucose homeostasis, and lipid metabolism. In addition, the proposed career development plan will provide Dr. Stanley will further training in statistics and drug development. The mentor in this proposal, Dr. Steven Grinspoon, is an internationally recognized expert in the field of HIV-associated endocrine and metabolic complications. In addition to being a well-established and well-funded clinical researcher, he is an accomplished mentor with the skills and infrastructure necessary to mentor Dr. Stanley and help her transition to independence. Along with the mentorship of Dr. Grinspoon, the career development plan proposed in this application will provide Dr. Stanley with the training and skills to become an independent clinical investigator.

Public health relevance
PUBLIC HEALTH RELEVANCE: This project will determine the metabolic effects of a new therapy, growth hormone releasing hormone (GHRH1-44), to reduce abdominal fat and improve metabolism in patients with HIV-infection and increased belly size. The research will contribute to our knowledge of this important potential therapy for complications of HIV-infection, and will also increase our understanding of how growth hormone affects sugar and fat metabolism. 7. Project Narrative This project will determine the metabolic effects of a new therapy, growth hormone releasing hormone (GHRH1-44), to reduce abdominal fat and improve metabolism in patients with HIV-infection and increased belly size. The research will contribute to our knowledge of this important potential therapy for complications of HIV- infection, and will also increase our understanding of how growth hormone affects sugar and fat metabolism. __SpecificAimsTextDelimiter__ 10. Specific Aims Treatment of HIV-infection with antiretroviral therapy has substantially reduced mortality but has contributed to increasingly prevalent metabolic and endocrine comorbidities, including increased visceral adiposity, dyslipidemia, and insulin resistance, which may contribute to the increased risk of cardiovascular disease in this population (3-6). More than half of individuals with HIV-infection demonstrate abnormal body fat partitioning, with increased abdominal and dorsocervical fat and/or decreased fat in the face and limbs. Recent data suggest that visceral fat accumulation is associated with increased rate of coronary calcification progression, independent of other CVD risk factors (7). In addition, data also demonstrate increased ectopic fat accumulation in liver and muscle in association with overall fat redistribution and insulin resistance among HIV-infected patients chronically treated with highly active antiretroviral therapy (8-11). Increased lipid storage in muscle and liver may further contribute to the metabolic dysregulation in HIV-infected patients. These data thus suggest a critical need for therapies to decrease visceral adiposity and ectopic fat accumulation in the HIV population. Indeed, developing therapies to treat these comorbidities is a high priority goal in the 2010 Trans- NIH Plan for HIV-Related Research. HIV-infected patients with abdominal fat accumulation demonstrate decreased endogenous growth hormone (GH) secretion, characterized by decreased GH pulse amplitude with preserved GH pulsatility (12). Use of recombinant human GH (rhGH), even at physiologic doses, reduces visceral fat but increases glucose (13-16). One possible reason for this is that standard once-daily rhGH increases GH levels in an apulsatile fashion and may reduce endogenous GH pulsatility. Our group has investigated an alternative therapeutic strategy in this population, the use of growth hormone releasing hormone (GHRH1-44), which was shown to decrease visceral fat by 18% and ameliorate dyslipidemia without changing glucose homeostasis as measured by oral glucose tolerance test (OGTT) over one year of administration in HIV-infected patients (17). In contrast to exogenous rhGH, GHRH1-44 augments endogenous GH secretion while preserving the negative feedback of IGF-I on pituitary GH production, thereby potentially limiting side effects. Despite the success of GHRH1-44 in initial studies, little is known regarding the physiological effects of GHRH1- 44 on GH pulsatility parameters. Moreover, the relationship between enhanced endogenous GH production and reduction in ectopic fat in liver and muscle has not been previously investigated. In this K23 proposal, the physiologic effects of short-term GHRH1-44 on GH pulsatility will be compared for the first time with rhGH itself, with the hypothesis that one strategy enhances endogenous GH pulsatility while the other suppresses it, potentially explaining the differential effects on glucose that have been observed to date in clinical studies. Moreover, the longer term effects of GHRH1-44 as a strategy to augment endogenous GH will be investigated for physiologic endpoints including liver and muscle fat, lipolytic rates, and insulin sensitivity, with attention to the relationship between changes in pulsatile GH parameters over time to changes in critical metabolic and body fat parameters. The proposed physiological studies not only will be important for the HIV-infected population, but also will contribute to a better understanding of the physiologic relevance of the pulsatile pattern of GH secretion in human metabolism. In addition, data obtained from the planned studies will be useful for the development of optimal strategies to reduce visceral fat in other conditions of pediatric and adult central fat accumulation. Preliminary data presented in support of this application suggest that GHRH1-44 preserves pulsatile GH secretion, whereas exogenous rhGH therapy suppresses pulsatile GH secretion. Consequently, we propose to definitively characterize effects of GHRH1-44 on detailed measures of GH pulsatility, insulin sensitivity, and lipolysis in healthy control subjects and then contrast these effects with those of rhGH in a short term study. We will then investigate the longer-term effects of a strategy to increase pulsatile GH on critical fat depots, including liver and muscle, not previously studied in response to GHRH1-44 among HIV-infected patients. Specific Aim I. We hypothesize that GHRH1-44 will increase endogenous pulsatile GH secretion and significantly increase IGF-I without aggravating insulin sensitivity. These effects will contrast to those of rhGH, which will increase IGF-I to a similar degree but will reduce pulsatile GH secretion and aggravate insulin sensitivity in a dose dependent manner. We further hypothesize that administration of rhGH will cause suppression of endogenous GH that persists after treatment withdrawal. Aim Ia: To fully characterize the effect of GHRH1-44 on pulsatile pituitary GH secretion, we will assess the effect of GHRH1-44 on endogenous GH secretion parameters using detailed deconvolution methodology, and assess glucose and lipid metabolism using detailed measures of insulin sensitivity and lipolysis in healthy, non- HIV infected subjects. We will administer GHRH1-44, 2mg daily x 14 days, followed by a 14 day wash-out period. At 0, 14, and 28 days, we will measure overnight endogenous GH secretion, insulin sensitivity, and lipolytic rate. Aim Ib: Among HIV-infected patients with visceral fat accumulation, we will compare the differential effects of short-term GHRH1-44 vs. two doses of rhGH on endogenous GH secretion, glucose metabolism, lipolysis, and IGF-I and IGF binding protein levels. We will compare GHRH1-44 vs. a relatively low, purely physiologic dose of rhGH designed to achieve a comparable increase in IGF-I vs. a relatively higher dose of rhGH representing the less physiologic doses often used in this population in clinical investigation. Subjects will receive treatment for 14 days, followed by a 14 day washout period. At 0, 14, and 28 days, we will measure overnight endogenous GH secretion, insulin sensitivity, rate of lipolysis, IGF-I, and IGFBP-3. Specific Aim II: We hypothesize that longer-term GHRH1-44 will reduce ectopic fat in the liver and muscle, as well as the visceral compartment, in HIV-infected patients with abdominal fat accumulation, and that the degree of this reduction in ectopic fat will relate to the degree to which GHRH1-44 enhances endogenous GH pulsatility rather than the degree to which it increases IGF-I. We further hypothesize that reductions in ectopic fat will improve insulin-stimulated glucose uptake in muscle. Aim IIa. To investigate the longer-term effects of GHRH1-44 in patients with HIV-infection and abdominal fat accumulation, we will take advantage of an NIH funded, 27 month, double-blind, crossover study in which 60 subjects will receive GHRH1-44 2mg/day vs. placebo. In contrast to specific cardiac endpoints which are the primary focus of the parent study (R01DK63639 to mentor S. Grinspoon), physiologic endpoints of GH pulsatility, lipid metabolism, ectopic fat accumulation, and insulin sensitivity will be measured after one year of treatment in the placebo vs. GHRH1-44 groups as the focus of the proposed mentored patient-oriented research award. Detailed measurement of insulin sensitivity by euglycemic hyperinsulinemic clamp, rate of lipolysis by stable isotope tracer infusion, intramyocellular lipid and hepatic fat by MR spectroscopy of the calf muscle and liver, and visceral adipose tissue by single-slice abdominal CT scan will be performed Aim IIb. To discern the importance of GH pulse parameters vs. IGF-I concentration in affecting physiologic endpoints, we will use data from the above protocol to compare changes in lipolytic rates, ectopic fat depots, and insulin sensitivity to specific changes in GH pulsatility as determined by deconvolution analysis and to changes in IGF-I levels.